Neonatal Stress in Very Preterm Infants: Longitudinal Effects on Epigenetics and Neurodevelopment

PROJECT SUMMARY (See instructions):
Preterm birth affects 1 in 10 infants born in the United States, resulting in significant morbidity and economic cost.
Children who are born very preterm (VPT; gestational age<32 weeks) have increased risk for impaired
neurodevelopment. VPT infants experience increased physiologic stress while their caregivers experience
increased psychological distress-both are associated with impaired neurodevelopment. Epigenetic modifications
are proposed as a possible mechanism linking physiologic stress and neurodevelopment in VPT infants. The main
objective of the proposed research is to identify the mechanisms by which neonatal physiologic stress induces
epigenetic modifications that contribute to impaired neurodevelopment, as well as how caregiver distress
moderates the relationship between longitudinal neonatal physiologic stress and neurodevelopmental outcomes.
Specifically, the proposed research aims to (1) create and validate novel indices of neonatal physiologic stress in
VPT infants; (2) identify the effects of neonatal physiologic stress on epigenetic modifications and later
neurodevelopment in VPT infants; and (3) determine the effects of caregiver distress on neurodevelopment in VPT
infants. This aligns with the NICHD Strategic Plan 2020 scientific priority-to reduce the incidence of
neurodevelopmental disorders by improving the understanding of their origins in the developmental process and
identifying potential targets and optimal timing for intervention. During the K99 phase, the Pl's molecular genetic
expertise was further developed by adding training in epigenetic analyses via intensive workshops and laboratory
experiences, and the Pl's quantitative expertise was expanded to include complex longitudinal analyses.
Additionally, the Pl has gained exposure and knowledge of neonatal physiology via the neonatal hemodynamics
program at the University of Iowa, led by Drs. McNamara and Rios. Finally, the Pl has developed professional
development skills that will be critical for success as a tenure track assistant professor and independent clinical
scientist. The academic environment at the University of Iowa is well-suited for the proposed research. Faculty
members with expertise in advanced quantitative methods, epigenetics, and neonatal physiology are willing to
continue to provide expert mentorship to the Pl as a junior faculty member. The Division of Neonatology conducts
numerous research studies on preterm birth each year and has the infrastructure, including an outstanding team of
clinical research nurses and a high-risk infant follow-up clinic, to support the proposed research. The Iowa Institute
of Human Genetics provides researchers with a state-of-the-art, high-throughput genetic analysis facility and
supports research focused on human genetics Numerous institutional organizations provide a variety of
opportunities to develop the skills necessary for success as an independent clinical scientist.

Public health relevance
RELEVANCE (See instructions): There is a need to uncover the etiological mechanisms underlying the association between preterm birth and impaired neurodevelopment, both to improve the identification of the preterm infants who are at higher risk for impaired neurodevelopment and to inform efforts towards neurodevelopmental interventions. This project will provide much needed data to pave the way for novel opportunities for neurodevelopmental prevention and intervention efforts for preterm infants, and thus, decrease the incidence of neurodevelopmental disabilities and morbidities.